Lesion Analysis/Biostatistics Core

Core A – Project Summary/Abstract
The Lesion Analysis/ Biostatistics Core will continue to provide support to each of the three
projects in study design and assessment of atherosclerotic lesion development. The Core
ensures consistent quantitative and qualitative assessment of atherosclerotic lesions,
adequately powered experimental design and appropriate analysis of experimental results
across all three projects of the PPG. Specifically, the Core will provide state-of-the-art expertise
in A) quantification of atherosclerotic lesions; B) qualitative assessment of lesion composition;
C) apoptosis and in situ efferocytosis assays; D) markers of cell adhesion and inflammation; E)
laser-capture microdissection (LCM) for cell-specific quantitative gene expression analyses; and
F) biostatistical support including study design and power analyses. In addition, the Core will
provide biostatistical support for genome-wide transcriptomic and chromatin analyses via the
expertise of Dr. Ying Wei, Professor of Biostatistics.

Public health relevance
Core A – Narrative A recent public health report by the Centers of Disease Control indicated that, for the first in decades, deaths from heart disease and incidence of stroke are increasing while life expectancy is decreasing in the US. An obesity epidemic is driving the increased incidence of diabetes and coronary heart disease. Core A provides expertise and consistency in the quantitative and qualitative assessment of atherosclerosis, the major disease underlying CHD in humans, and statistical support for genomic approaches to understand the link between obesity, insulin resistance and atherosclerosis.